Role of PI 3-Kinase Isoforms in Insulin Action

Project Summary/Abstract This is a revised competitive renewal of NIH grant DK055545 which is focused on the role of phosphatidylinositol 3-kinase (PI3K) in insulin action and insulin resistance. PI 3-kinase is a critical node in insulin's metabolic actions. Alterations in PI3K have been implicated in cancer, diabetes and many other disorders. In previous work under this grant we have used both in vitro and in vivo approaches to define the role of this enzyme in insulin action and insulin resistance. We have shown that regulation of PI3K depends both on the nature of the different regulatory subunits; the stoichiometry between regulatory and catalytic subunits; the ability of PI 3-kinase to serve as a site for divergence of downstream signaling; and alterations in PI3K activity in disease states. We have also identified new links between the PI 3-kinase pathway and other signaling pathways, including important links between the p85 regulatory subunits and several pathways involved in insulin resistance, such as activation of the stress kinases JNK and p38, regulation of the PIP3 phosphatase PTEN, and a novel link between PI 3-kinase, endoplasmic reticulum (ER) stress and the unfolded protein response (UPR) created by the interaction between p85α and XBP-1s, facilitating XBP-1s transport into the nucleus and thus modifying the ER stress response. Another exciting recent development has been the identification of a mutation in p85α in patients with SHORT syndrome, a syndrome characterized by insulin resistance and partial lipodystrophy. Recently, we have created a knock-in mouse bearing this mutation to study its effects in vivo. We have also begun to characterize the different roles of the two major catalytic subunits of PI3K (p110α and p110β) in insulin signaling and mitochondrial homeostasis through knockout in vivo and in vitro. This has led to new hypotheses about the unique roles of the different catalytic and regulatory subunits of PI 3-kinase, which allow these proteins to serve as both sites of divergence in the insulin signaling pathway and sites of positive and negative regulation in physiological and pathological states. In the next five years, we propose to expand upon these observations by defining at both the molecular and physiological levels how different signals are generated by the p110α and p110β catalytic subunits of PI 3- kinase, the specific signaling complexes involved, and the link between PI3K and mitochondrial homeostasis. In addition, we will expand our studies on the regulatory subunits focusing defining the regions of p85α that interact with XBP-1s creating crosstalk between the PI 3-kinase pathway and ER stress. We will also further define how mutations in the p85α regulatory subunit can have a dominant negative effect and result in severe insulin resistance. Together, these studies will help complete our understanding of the role of the PI3K system and its different catalytic and regulatory subunits in insulin action and insulin resistance.

Public health relevance
Narrative: Over 29 million people in the U.S. have diabetes mellitus, and the central pathway involved in insulin regulation of metabolism is the PI 3-kinase pathway. PI 3-kinase is a heterodimer consisting of one of eight different regulatory subunits and one of three different catalytic subunits. The major goal of this grant is to dissect how these different catalytic and regulatory subunits interact; how they interact with their downstream signals to create the multiple metabolic actions of insulin on glucose, lipid and protein metabolism; and how these pathways are altered in diabetes and other insulin resistant states.